Coding of auditory space in the avian brain

DESCRIPTION (provided by applicant): All auditory information used for sound localization ascends through the brainstem auditory nuclei. We will use physiological and theoretical approaches to understand how multidimensional features of sound, relevant to sound localization, are processed and encoded in the avian auditory brainstem. A primary advantage of using barn owls for the exploration of auditory processing is the substantial body of behavioral, anatomical and neurophysiological work that has elucidated the mechanisms of sound localization. The main cues owls use to compute sound direction are the interaural level difference (ILD) and the interaural time difference (ITD). Unlike mammals, owls use ILD to determine the vertical coordinate of the sound source and ITD to determine the horizontal coordinate. Two independent brainstem pathways process ITD and ILD and converge in the midbrain, where a spatiotopic map of auditory space emerges. Activity of neurons in the map precedes, and stimulation evokes, a head-orienting response towards the sound source. Thus, in barn owls, the neural algorithm for sound localization can be viewed as a system in which two input variables (ITD and ILD) are processed in parallel in order to control two output variables (horizontal and vertical coordinates of head saccades). We have used theoretical models to describe the neural responses that encode spatial information in the owl's auditory system. This approach has guided our experiments and aided the interpretation of our findings. Behavioral experiments in humans have used a similar approach to sound localization. However, due to a lack of neural data in humans, the predictive power of models of sound localization with regard to the neural bases of behavior has been a persistent question. Our studies in barn owls address this issue by investigating the mechanism of neural computations that are fundamental to models developed for human sound localization. This proposal is organized around three primary questions: 1) What are the computational primitives of auditory-space processing in the owl's brainstem? 2) How is spectrotemporal information encoded, transmitted and processed in parallel with spatial information? 3) What fundamental changes in information coding occur at the crossroads between the auditory midbrain and forebrain? We will address these questions using a wide range of strategies and techniques - intracellular in vivo recordings, cell-attached recording in vivo, multi-neuron tetrode recording, and modeling - which will make our approach interdisciplinary and of broad scope. Our research seeks to understand the function of the auditory brainstem and midbrain. In doing so, we will identify the types of information that are available to upstream nuclei and show how this information is encoded. A comprehensive approach to information processing in the auditory brainstem has the potential to provide new avenues for better understanding disorders of the central auditory system and cognitive impairments involving hearing. By linking biology and engineering, mathematical formulations of brain processes can advance technology related to robotics and neural prosthetics. Cochlear implants that provide encoding of stimuli in ways that are more biologically relevant can be built, while devices acting downstream of the cochlea could aid patients with compromised or non-functional auditory nerves. By its differences and similarities with other species, the avian brain provides an excellent model system to define fundamental properties of neural processing and neural coding.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research will test hypotheses based on human models, of how the auditory system computes sound direction. This approach has the potential of providing new avenues for better understanding disorders of the central auditory system and cognitive impairments involving hearing. By linking biology and engineering, mathematical formulations of brain processes can advance technology related to artificial intelligence and neural prosthetics; smarter cochlear implants can be built, as well as devices acting downstream of the cochlea could aid patients with compromised or non-functional auditory nerves. The proposed research will test hypotheses based on human models, of how the auditory system computes sound direction. This approach has the potential of providing new avenues for better understanding disorders of the central auditory system and cognitive impairments involving hearing. By linking biology and engineering, mathematical formulations of brain processes can advance technology related to artificial intelligence and neural prosthetics; smarter cochlear implants can be built, as well as devices acting downstream of the cochlea could aid patients with compromised or non-functional auditory nerves. __SpecificAimsTextDelimiter__ To determine the spatial location of acoustic objects, the brain compares the time-dependent structure of the signals that arrive at each ear. We seek to understand the neural mechanisms that underlie sound localization. Our findings have so far uncovered a remarkable correspondence between models of human sound localization and the processing of auditory signals by the barn owl's auditory pathway. The owl, an auditory specialist, offers a unique system in which to merge experimental neuroscience with theoretical approaches used to understand auditory physiology. We propose an integrative study of how information flows in the owl's auditory brainstem, giving rise to different types of representations of auditory space. Through its ease of experimental access, the owl's auditory pathway brings this goal within reach. We have three major objectives for this project. First, we will investigate the computational primitives of auditory spatial processing; second, we will study how spectrotemporal information is transformed through the brainstem; third we will explore how this processing leads to different coding schemes of auditory space in the midbrain and the forebrain. How information is transmitted, processed and encoded in the auditory brainstem is the question that links these three aims. The neural computations studied in the first aim are essential for understanding the emergence of spectrotemporal tuning and its propagation along sequential stages of the brainstem. In turn, understanding the neural computations and the diversity of coding dimensions implemented in the brainstem auditory pathways will allow us to investigate the transformations in auditory spatial coding that take place between the midbrain and the forebrain with a broader and integrative scope. Aim 1. Elucidate the neural bases of mathematical operations to infer sound direction. Models of human sound localization use mathematical formulations to describe comparison of signals from the left and right ears, noise reduction, and combination selectivity leading to spatial tuning. Cross-correlation has been used as a mathematical correlate of comparison, averaging has been used to extract signals from noise, and multiplication to generate combination selectivity. In the owl's auditory pathway, we have found neurons that effectively perform these types of processing. However, the mechanisms of these fundamental computations remain unknown. Guided by theory, we will investigate the physiological mechanisms of cross-correlation, averaging and multiplication in the auditory system. Aim 2. Investigate how spectrotemporal information is encoded and communicated in the auditory brainstem. The spectrotemporal properties of sound are essential to identify acoustic objects and accurately locate them in space. In the auditory brainstem, this information must be encoded in parallel with binaural cues used for sound localization. The owl's auditory brainstem, however, has mainly been studied in terms of the two major binaural cues, interaural time (ITD) and level (ILD) differences. While spectrotemporal coding has been examined in some parts of the ITD pathway, it has not been studied in the avian auditory nerve, cochlear nuclei or in the pathway that encodes ILD. Given the degree of understanding of computations and connectivity in the owl's auditory pathway, studying spectrotemporal properties in this system can reveal how this information propagates and how complex receptive fields emerge downstream. Our preliminary data suggest that envelope coding, a phenomenon directly related to spectrotemporal tuning, differs in the ITD and ILD pathways. Surprisingly, the ILD pathway conveys this information more reliably than the ITD pathway. We will investigate the mechanisms underlying this difference and elucidate how information related to the envelope and the fine-structure of sound propagates in the brainstem. Aim 3. Determine the transformation in spatial processing at the crossroads of the midbrain and the forebrain. The barn owl's midbrain and forebrain contain representations of auditory space. The spatial receptive fields of the neurons located in these areas result from sensitivity to ITD and ILD. Yet, there exist significant differences in the encoding of spatial information by the midbrain and forebrain. While a map of auditory space has been described in the midbrain, no topographic representation of space has been found in the forebrain. The first nuclei that belong exclusively to the forebrain and midbrain pathways are, respectively, the thalamic nucleus ovoidalis (Ov) and the external nucleus of the inferior colliculus (ICx). Ov cells respond to a broader frequency range, have greater variability in ITD and ILD tuning, and have no clear topographic organization. However, we have found that spatial tuning in Ov can be as selective as in ICx. Thus, differences between forebrain and midbrain processing first appear in the thalamus. One fundamental difference between topographic and non-topographic representations is the pattern of lateral connectivity that can be implemented and its consequence on population coding. Topographic representations can support local spatiotopic lateral connectivity whereas non-topographic areas do not. Thus, we predict that population coding will differ in these two organization schemes. We will approach this aim by recording clusters of spatially-tuned neurons in the midbrain and the forebrain. 1